Alterations of leukocyte integrin signaling leading to diabetes and autoimmunity

Project Summary/Abstract
The study of the genetic basis for type 1 diabetes (T1D) has benefited tremendously from examination of rare
individuals with likely monogenic forms of the disease. Combined with GWAS, a number of polymorphisms in
immune regulatory genes have been defined that contribute to genetic risk for T1D. Using whole exome
sequencing of individuals with T1D enrolled in a monogenic diabetes registry, we identified an individual with a
gain-of-function mutation in the SKAP2 gene, as well as several other T1D patients with potentially pathogenic
variants in other leukocyte integrin signaling genes. These patients tend to have a number of autoimmune
manifestations in addition to T1D, indicating defects in critical pathways of immune tolerance. Multiple GWAS
studies have identified a strong genetic linkage between SKAP2 polymorphisms and T1D (at a frequency of
~20%), however the mechanisms by which alteration of SKAP2 could lead to autoimmune T1D are unknown.
SKAP2 is expressed primarily in myeloid cells, where it functions as an adapter protein in the integrin signaling
pathway, linking cell surface integrins to WASP and actin rearrangements that occur following leukocyte
adhesion. The SKAP2 G153R mutation in our patient resulted in constitutive association of SKAP2 with WASP
leading to a hyperadhesive phenotype in macrophages cultured from the patient or macrophages engineered
to contain the SKAP G153R substitution. To understand how activation of leukocyte integrin signaling may
contribute to T1D, we have generated knock-in (KI) mice containing the G153R substitution in murine Skap2,
on the NOD genetic background. Female NOD.SKAP2 KI mice have a higher incidence and earlier onset of
T1D than do NOD.WT animals; male NOD.SKAP2 also develop T1D (incidence ~50%) while male NOD.WT
do not develop frank hyperglycemia. Initial analysis of these mice reveals evidence of ongoing inflammation
early in life with development of a broad spectrum of auto-reactive antibodies. Dendritic cells from
NOD.SKAP2 KI mice have increased antigen presenting activity to islet-specific transgenic T-cells while
neutrophils from these mice show evidence of increased integrin signaling. These observations demonstrate
that the NOD.SKAP2 KI mice appropriately model the autoimmune T1D disease observed in our patient. The
project proposes to complete the analysis of these mice, under the hypothesis that increased cell adhesion in
dendritic cells leads to prolonged DC-T cell interactions, which drives selection of auto-reactive T-cell clones
leading to development of T1D, associated with broad spectrum autoimmunity. We will test this hypothesis in
a variety of adoptive cell transfer experiments, by generation of conditional knock-in mice and by imaging of
DC-T cell interactions in the inflamed islets. Similar studies will be performed for other candidate leukocyte
integrin signaling mutations identified in the monogenic T1D registry. This study will address whether
dysregulation of leukocyte integrin signaling may constitute an unrecognized genetic risk factor for T1D,
suggesting potential alterative therapeutic approaches for these patients.

Public health relevance
Project Narrative This genetic study focuses on type 1 diabetes mutations in the protein coding region of the human genome, which are potential biological targets for treatment. We are generating mice and human cell lines to understand how these mutations cause diabetes, as well as using these animals as preclinical models for evaluating possible precision therapies. The results from this study will enable better detection, prediction, and treatment for patients with type 1 diabetes, and may also benefit individuals with other autoimmune disorders.